Changes in Alcohol Use and Harsh Parenting during COVID-19

PROJECT SUMMARY
The role of alcohol use in the etiology of abusive parenting is a significant known risk. The COVID-19
pandemic is a health, economic, and social crisis that has radically changed supports available for parenting,
particularly as many parents may have lost jobs or had to navigate working from home while monitoring their
child(ren)’s virtual and/or hybrid schooling. Further, COVID-19-related distress is associated with drinking-
related coping, which in turn is related to increased frequency and quantity of alcohol use. While the full impact
may not be known for years, it is likely that increased parent-child time within the home may mean an increase
in child abuse and neglect that is hidden from mandated reporters who are an important front-line defense in
keeping children safe (e.g., teachers, childcare providers). In our innovative study, we asked mothers directly
about their use of aggressive and punitive parenting practices (which correlate with use of child abuse neglect)
three times a day for 14 days mid-March through April 2020, during Ohio’s stay-at home orders and again
during February 2021, before vaccinations were widely available and when most schools were in hybrid or fully
virtual formats. Thus, our understanding of changes in parenting do not rely on official reports of child abuse
and neglect during the COVID-19 pandemic. The proposed study capitalizes on two existing waves of data
collection by adding a third wave of data of mothers in Central Ohio that assesses alcohol use and parenting
behaviors to occur 6–12 months after most social distancing and other COVID-19 restrictions have been lifted.
This represents a unique opportunity to assess how alcohol use has changed and affected use of aggressive
and punitive discipline during and after the COVID-19 pandemic. Importantly, our study combines use of a
baseline survey and Ecological Momentary Assessment for all three time periods to assess past year and at-
the-moment stress, drinking, and parenting behaviors. This provides us with important information on
behaviors pre-pandemic while also being able to assess micro-temporal changes in daily alcohol use and
parenting during and after social distancing and other pandemic restrictions have been lifted. The specific aims
of the study are:
Aim 1: Examine change in drinking behaviors during three time points of the COVID-19 pandemic: (1)
during Ohio’s first stay-at-home orders; (2) about one year into the pandemic; and (3) 6–12 months after re-
opening occurred;
Aim 2: Test whether daily drinking during and post-pandemic were related to at-the-moment aggressive and
punitive parenting; and
Aim 3: Investigate if daily drinking moderates the relationship between at-the-moment stress and aggressive
and punitive parenting during the pandemic and if that changes when re-opening has occurred.

Public health relevance
PROJECT NARRATIVE Our study assess changes in alcohol use and corresponding changes to parents during and post-pandemic. In the short-term, we will identify how drinking behaviors and use of aggressive and punitive discipline changed over the course of the pandemic. In the longer term, insights gained from this study will help to identify strategies to help reduce problematic alcohol-related parenting, particularly when parents are under extreme forms of stress due to natural or worldwide disasters.